Pediatric ECHORN Cohort Study: intergenerational factors that contribute to cardiovascular risk in the Eastern Caribbean

Abstract: The epidemic of obesity among racial/ethnic minority children has been compounded by a disturbing increase in other pediatric cardiovascular risk factors such as hypertension and hyperlipidemia. The Pediatric Eastern Caribbean Health Outcomes Research Network Cohort Study (P-ECS) was established to characterize the intergenerational factors that contribute to pediatric cardiovascular risk. The proposed Research Supplement to Promote Diversity in Health-Related Research layers community-level data collection onto rich individual-level data collected by the Adult ECHORN (A-ECS) and P-ECS. The work will be conducted in a single ECHORN site (Barbados), with one aspect of the work exploring the feasibility of expanding the methods to the other ECHORN sites and developing a toolkit for expansion across the network (USVI, Puerto Rico & Trinidad). Our aims center around the concept of walkability and its impact on overall health and wellness. Our intention is to focus on detailed neighborhood characterization, subsequently linking this characterization to new data collected on individual- level health outcomes measured in the P-ECS. We will focus on both macroscale and microscale environmental features. To our knowledge, this type of neighborhood characterization has not been attempted in the Caribbean region; nor has the influence of different neighborhood characteristics on individual-level walking behavior been examined.

Public health relevance
Narrative: The proposed Research Supplement to Promote Diversity in Health-Related Research will (1) design an investigation of macroscale walkability among P-ECS neighborhoods in Barbados and (2) conduct microscale street audits via ground truthing within P-ECS enumeration districts using 500m and 1000 m buffers from selected participant's homes.